Technologies Advancing Translation and Equity - Regional Core

REGIONAL CORE: PROGRAM SUMMARY / ABSTRACT
Disparities in diabetes prevention and care are pronounced in the Southeast, and there is an unmet need for
translation research that evaluates and advances the role of technology in both providing continuity of care and
minimizing healthcare inequities. The COVID-19 pandemic has highlighted how the accelerated use of
technologies (e.g., expansion of telehealth) has helped healthcare systems accommodate patient and provider
needs while minimizing viral exposure risk. Numerous barriers have been identified that may hinder the
implementation of such technologies in communities and clinical practices, and little is known about the impact
that this technological revolution in healthcare will have on vulnerable populations. In addition to telehealth,
other technological advances include multiple interfaces and interoperability that allow for remote monitoring
and population health management. However, access to this type of technology in disadvantaged populations
is often low. At the same time, smartphone ownership has grown rapidly in the US (~80%), including among
those with lower incomes, and people are turning to the internet for advice, coaching, connection, and health
care like never before. It is also important to consider the way technologies are implemented in certain
populations, given that continued rapid technological advances and overwhelming marketing can sometimes
widen the technology gap and increase disparities. Additionally, poor implementation can lead to early
discontinuation of technology use that might have been beneficial long term. As such, the Regional Core
(Technologies Advancing Translation and Equity) of the Georgia Center for Diabetes Translation Research
(GCDTR) will combine, a priori, technologies with implementation science to optimize the reach, adoption,
impact, and sustainability of technologies for diabetes and disparities reduction. The Core will achieve its goal
by: a) establishing a Collaborative Learning Network across Georgia, Florida, and Tennessee to enhance
knowledge sharing activities focused on technological approaches in diabetes prevention and care (Aim 1); b)
providing expertise and consulting in five key technological diversity driven approaches; interactive
technologies; wearables; artificial intelligence and Big Data; and electronic health records integration and
clinical decision support with specific guidance on reducing disparities and promoting equity (Aim 2); and c)
funding projects that inform how to optimize the reach, adoption, implementation, effectiveness, and
maintenance of technologies to improve and reduce inequities in diabetes prevention and care (Aim 3). In
close collaboration with the GCDTR's Pilot and Feasibility and Enrichment Programs and other Cores, the
Regional Core will advance the availability, accessibility, and usability of key technologies that promote
equitable and cost-effective diabetes prevention and management across partner institutions in the region. The
Regional Core will also share its expertise and material with the wider CDTR network nationally.